Brain-based Mechanisms of Emotion Regulation in Aging and Mood Disorders

PROJECT SUMMARY
Effective emotion regulation (ER) requires the ability to flexibly and dynamically respond to affectively-valenced
stimuli in the service of goal-directed behaviors. Patients with major mood disorders, including bipolar disorder
(BD) and major depressive disorder (MDD) are characterized by brain-based abnormalities in affective
processing and cognitive deficits that make it difficult for them to regulate their emotions. Disruptions in ER are
thought to play a role in risk for onset of illness, a relapsing course, and incomplete remission. Aging may amplify
poor outcomes in older adults with depression, as reflected in a more severe course and treatment resistance. In
contrast, in healthy adults, ER improves across the lifespan with a shift from attending to negative to attending to
positive stimuli in attention, learning and memory.
Consistent with RDoC, we will leverage multiple units of analysis (circuit, performance, self-report) in a
transdiagnostic sample enriched for a range of ER-related network functions, implicit attentional biases, and ER
strategies. We will enroll 200 adults (ages 41-80) with an affectively-stable mood disorder (100 BD, 100 MDD),
and 100 demographically-matched healthy controls, allowing us to capture the range from extreme positive to
extreme negative emotional experience. We will assess performance-based affective biases, cognitive control,
and resting-state functional connectivity (FC), to define age-related changes in ER circuitry. We will assay
habitual use of ER strategies, social functioning, and well-being to determine how brain-based processes affect
these functionally- and clinically-relevant outcomes.
Impact. The goals of this project are directly aligned with the NIMH Strategic Plan to develop new ways of
characterizing and treating mental illness that are predicated on understanding brain-based mechanisms.
Beyond the heuristic value of understanding the specific mechanisms and developmental trajectory of ER in mid
and late life, results can be used to inform the development of novel interventions (e.g., neurostimulation,
cognitive interventions) designed to “rescue” the specific network dysfunctions that give rise to maladaptive ER
in depressive disorders.

Public health relevance
PROJECT NARRATIVE Major mood disorders are characterized by an inability to regulate one’s emotions; an impairment that can be mapped onto abnormalities in brain circuits that underlie the salience of affectively-laden material and higher- order cognitive control. These deficits contribute to maintenance of the illness as well as functional disability, and they may worsen with age; a pattern which is in contrast to the improvement in emotion regulation noted in healthy older adults. A better understanding of these complex age-related brain changes could point toward novel targets for intervention to promote improved well-being in patients suffering from disabling mood dysregulation.